The role of the lung microbiome in oxygen-induced lung injury

PROJECT SUMMARY/ABSTRACT
Background and long-term objectives: This proposed research will advance our understanding of how the
lung microbiome contributes to the pathogenesis and perpetuation of oxygen-induced lung injury. Inhaled
oxygen is among our most commonly administered therapies. Yet hyperoxia - elevated inspired oxygen -
causes lethal lung injury in animals, and in humans is associated with increased mortality and development of
the acute respiratory distress syndrome. We have recently discovered that hyperoxia acutely alters lung
microbiota. This oxygen-induced dysbiosis is strongly and temporally correlated with alveolar inflammation. We
have discovered that germ-free mice - experimental mice devoid of microbiota - are protected from oxygen-
induced lung injury, an observation that cannot be explained via our conventional model of oxygen-induced
lung injury. Conversely, lung injury alters lung microbiota by changing bacterial growth conditions within the
lung microenvironment. We have discovered that germ-free mice are protected from non-resolving lung injury
(bleomycin), indicating that the microbiome is necessary for perpetuation of lung injury. The discovery of the
lung microbiome has thus broadened our model of pathogenesis. The mechanisms by which lung microbiota
mediate oxygen-induced lung injury, and are in turn altered by lung injury, are undetermined.
The central hypothesis of this proposal is that specific bacteria within the lung ecosystem propel alveolar
inflammation in oxygen-induced lung injury, and these bacteria are enriched within the lung microbiome both
by hyperoxia itself and by the altered ecology of injured lungs. The rationale is that these discoveries will
facilitate the development of therapies for the prevention and treatment of oxygen-related human lung disease.
Specific Aim 1: To determine the microbial and molecular pathways by which oxygen therapy alters
lung microbiota, mediating host inflammation and injury. We will accomplish this Aim by integrating
complementary experimental approaches: in vivo heterogeneity analysis of host-microbiome interactions in
mice; in vivo germ-free, gnotobiotic, and antibiotic-treated hyperoxia modeling in mice; data science
interrogation of observational human data using a validated machine-learning algorithm.
Specific Aim 2: To determine the molecular pathways by which oxygen-induced host inflammation and
injury alter lung microbiota, perpetuating respiratory dysbiosis and lung injury. We will accomplish this
Aim by integrating complementary experimental approaches: a novel ex vivo culture assay that identifies host-
derived mediators of bacterial growth; in vivo augmentation and inhibition of the host response in hyperoxia.
This translational research approach will determine 1) the key members of the lung microbiome that mediate
oxygen-induced lung injury, 2) the pathways by which these bacteria promote alveolar inflammation, and 3) the
ecologic factors within the injured lung environment that promote their growth.

Public health relevance
PROJECT NARRATIVE Inhaled oxygen is among our most commonly administered therapies, yet hyperoxia - elevated inspired oxygen - causes lethal lung injury in animals, and in humans is associated with increased mortality and severe lung disease. We have recently discovered that the lung microbiome - the communities of microbes living in the respiratory tract - are altered by inhaled oxygen and necessary for the development of oxygen-induced lung injury. This proposed research plan will reveal how the lung microbiome contributes to oxygen-induced lung injury, and provide us with new ways to prevent and treat this common clinical problem.